Developmental Research Project Program

Project Summary – Montana INBRE Developmental Research Project Program
The overall goal of the MT INBRE V Developmental Research Project Program (DRPP) is to expand research
capacity at all institutions in the statewide network. This expansion will be facilitated by supporting and mentoring
junior investigators in their establishment of biomedical and health science research programs. The overarching
goals of MT INBRE V are to 1) diversify the biomedical/health sciences research network and student pipeline
in Montana, and 2) utilize this network to address the serious health concerns that face Montana’s rural and
Native communities. DRPP is integral to our achievements and a driver of reaching the goals of the MT INBRE
program. To achieve these goals, MT INBRE V will expand the transdisciplinary research capacity across
Montana’s partner institutions--6 primarily undergraduate institutions (PUIs), 7 tribal colleges (TCs), 1 community
college and 2 research universities. The DRPP is fully invested in the successful career trajectory of the
investigators themselves, as well as in the development of a pipeline of students determined to have careers in
biomedical research and healthcare. Three Specific Aims will be used a guide program efforts.
Specific Aim 1: Create a transdisciplinary biomedical research network and strengthen biomedical research
expertise and infrastructure across Montana that is sustained outside of MT INBRE. Specific Aim 2: Build a
diverse workforce for conducting biomedical and health science research across Montana. Specific Aim 3:
Establish a pipeline of students focused on biomedical research and healthcare careers.
MT INBRE Core facilities are closely integrated with DRPP to maximize project leader resources and inter-
institutional projects and training for faculty and students diversify perspectives and impacts of MT INBRE.